Assay development for the assessment of pregnancy risks in early pregnancy

Prenatal diagnostics play a pivotal role in early identification and management of pregnancy-related
risks, yet current methods lag in detecting conditions like fetal growth restriction and preeclampsia in
the first trimester. Akna Health Inc.'s CerviGuard diagnostic platform represents a groundbreaking
advancement, aiming to fill this critical gap by utilizing trophoblast-specific biomarkers identified in
cervical fluid samples for early risk stratification during the first trimester of pregnancy. Patient
specimens are collected noninvasively in an office setting, using the same procedure as a PAP smear.
The proposed Phase II study builds upon successful preliminary findings to validate the clinical utility
of the CerviGuard assay. Specific Aim 1 is a clinical utility study to refine and validate a biomarker
panel for early detection of adverse pregnancy outcomes, employing a learning set of 100 participants
followed by a broad-scale validation with 500 participants. This aim incorporates cutting-edge machine
learning and predictive modeling techniques to achieve unparalleled accuracy in pregnancy risk
stratification. Additionally, the development of proprietary antibodies will enhance assay specificity and
reliability, creating valuable intellectual property.
Specific Aim 2 endeavors to broaden the assay's clinical applicability by adapting the discovery
approach for compatibility with flow cytometry, facilitating widespread adoption in clinical laboratories.
The conversion to flow cytometry will be rigorously validated through a series of milestones, ensuring
that the assay's diagnostic accuracy and reliability are maintained across platforms.
Supported by a robust foundation of preliminary research, strategic collaborations, and a dedicated
team, this project promises to significantly advance the field of prenatal diagnostics. By enabling early
identification of at-risk pregnancies, CerviGuard has the potential to transform prenatal care, offering
personalized, preemptive interventions that safeguard maternal and fetal health. The successful
completion of this study will pave the way for extensive multicenter trials and commercialization,
marking a decisive step toward reducing the incidence of pregnancy-related complications, reducing
healthcare expenditures and enhancing prenatal care outcomes.

Public health relevance
We aim to introduce a first trimester testing platform to detect early pregnancy complications, allowing timely interventions for high-risk pregnancies. Using a non-intrusive method akin to a PAP test for specimen procurment, we will quantify protein biomarkers indicative of the risk level for pregnancy disorders. This approach will offer insights comparable to ultrasound but much earlier in the pregnancy, facilitating personalized care management. Our goal is to launch a point-of-care perinatal test, revolutionizing healthcare for mothers and their babies.